Neonatal anesthesia-induced delay of axon pruning in hippocampus

Project Summary Millions of human fetuses and infants are exposed every year to anesthetic drugs in doses that trigger widespread neuroapoptosis in the developing brains of rodents and non-human primates. Alarmingly, several clinical studies now link human infant anesthesia to cognitive deficits in later life. However, the adult mammalian brain has orders of magnitude more neurons that survive the insult than those that are deleted and why a young and pliable brain cannot recover from a brief anesthetic insult is not understood. A plausible hypothesis is that the surviving neurons form dysfunctional neural circuits. Indeed, neonatal exposure to anesthetic drugs deranges nearly every microscopic component of neural circuits, which, we hypothesize, compromises neural circuit function, synaptic morphology, and ultimately, cognition. For Specific Aim 1, we test the hypothesis that anesthetic drug interference with normal developmental axon pruning leads to neural circuit excitability in animals treated with ketamine as neonates. For Specific Aim 2, we test the hypothesis that ketamine-induced deficits in hippocampus-dependent memory and axonal pruning can be prevented through pharmacological enhancement of BDNF signaling pathways. During the tenure of the award, the applicant will benefit from a highly-tailored professional development curriculum that leverages the strengths of the University of Colorado, generally, and its Department of Anesthesiology, specifically. At the conclusion of the award, the applicant will have mastery of patch clamp electrophysiology, neurobehavioral, molecular, and morphological techniques that will help launch his career investigating the anesthesia effects on neural circuits. The applicant’s long-term goal is to identify safe and effective strategies that prevent anesthetic drugs from exerting deleterious effects, which will be a valuable contribution to the health and well-being of millions of infants and children worldwide.

Public health relevance
Project Narrative In infant rodents and non-human primates, ketamine anesthesia causes neurodevelopmental impairments into adulthood despite sparing the majority of neurons from apoptosis, leading us to hypothesize that the surviving neurons form dysfunctional neural circuits. Our goals are to understand the basic mechanisms of neural circuit dysfunction caused by neonatal ketamine exposure and to devise strategies that protect the developing brain against anesthetic insults. If we can identify methods that are safe and effective in preventing anesthetic drugs from exerting deleterious effects on neural circuit function while not interfering with the beneficial effects of these drugs, then our research will be a valuable contribution to the health and well-being of millions of human infants throughout the world.